Phenotypic profiling of bacterial stress response networks: A transformative framework for characterizing and predicting antibiotic targets and interactions

Project Abstract/Summary The Wellcome Trust estimates the death toll due to microbial pathogenesis to be 700,000/year. This number is expected to rapidly increase in the next decade if the rise of antimicrobial resistance remains unaddressed. As a first step to understanding the mechanisms of antibiotic resistance emergence, recent studies have explored the biological processes affected by antibiotics from a holistic cellular perspective. Results from these studies have challenged the traditional notion of each antibiotic eliciting a specific stress, revealing communication between bacterial responses that highlight the importance of probing systems-level cellular physiology and exploiting multi-dimensional phenotypes. Although many attempts have been made to characterize cellular response to antibiotics on a comprehensive scale, most of these studies suffer from the significant disadvantage of measuring bulk population-level responses. As most resistant mutants are a sub-population that dominates after selective antibiotic bottlenecks have been applied, bulk measurements that fail to account for single-cell behavior do not capture the entire spectrum of responses to antibiotic stress. I will leverage two key technological developments: 1) a high-throughput imaging and image analysis pipeline, and 2) a CRISPR interference library of essential gene knockdowns in the model organism Escherichia coli to answer fundamental questions about the bacterial response to antibiotics. I propose to use a combination of high-throughput microscopy and plate reader-based bulk measurements of fluorescent stress-response reporters to map response dynamics in E. coli under both oxygen-rich and anoxic conditions. I will combine morphological parameters and stress response information to build a rich landscape for phenotypic profiling that can be utilized to identify targets of novel antibiotics, predict antagonism in combinatorial therapies, and probe the fundamental wiring between pathways. To investigate the molecular mechanisms underlying the network architecture, I will employ CRISPRi genetic tools to alter drug-target expression and drug efflux. My overarching goal is to eliminate a key bottleneck in drug discovery and drug administration approaches—the identification of cellular targets for antibiotics with unknown mechanisms of action and prediction of combinatorial therapeutics with improved efficacy from the vantage point of stress- response activation. This study should accelerate the antibiotic discovery pipeline through rapid target identification while also contributing deep understanding of bacterial physiology to guide future research across a wide range of organisms.

Public health relevance
Project Narrative The rise of antimicrobial resistance is a significant problem that requires new strategies and fundamental discoveries. The consensus among global initiatives to curb the spread of antibiotic resistance is that the current need is to accelerate antibiotic discovery through phenotypic understanding of the biology of antibiotic action. My proposed studies will provide systems-level insight into the interconnected biological processes affected by antibiotics and will utilize this information to build new tools to accelerate antibiotic discovery.